Characterizing the Role of Autophagy in Type 1 Diabetes Development

PROJECT SUMMARY/ABSTRACT
Type 1 Diabetes (T1D) develops following autoimmune-mediated destruction of pancreatic β-cells and is caused
by a combination of genetic and environmental factors. However, the mechanisms that lead to autoimmune
targeting of the β-cell remain incompletely understood. One potential contributing factor is defective β-cell
autophagy. The autophagy pathway scavenges and degrades cellular proteins and organelles under conditions
of stress. Recently, our lab discovered that the pathway of autophagy is impaired in β-cells before clinical onset
of T1D. Based on this discovery, and other preliminary results, I hypothesize that dysfunctional β-cell autophagy
contributes to autoimmune targeting of β-cells by altering protein degradation and antigen production leading to
a change in β-cell–immune cell dialogue. Experiments in aim 1 will assess how β-cell specific deletion of an
essential autophagy enzyme (ATG7) in mice affects β-cell survival, stress response, immune cell
recruitment/activation, and neoantigen formation. In aim 2, experiments will determine how disrupted autophagy
alters β-cell peptide processing and islet immunogenicity. Completion of these aims will determine how impaired
β-cell autophagy alters β-cell health/survival, as well as pathways of protein degradation and antigenic peptide
formation. These results will help determine whether the autophagy pathway is a useful therapeutic target to
modulate disease course. This project and opportunity for fellowship training will also serve as an important
launch point for my future career as a physician-scientist. The methods learned and applied to answer these
questions will cultivate a diverse skillset of biochemical and molecular biology techniques to apply in future
translational focused research. Furthermore, my expanding knowledge on mechanisms of β-cell stress
pathways, β-cell autoimmunity, and disease development will help prepare me to become a successful
contributor in the field of diabetes research and pediatric endocrinology clinical care. This F30 award entails a
4-year training plan designed to achieve 4 main objectives: 1) develop technical skills and knowledge of important
concepts in diabetes research, 2) train in the use and handling of mouse models, 3) enhance written and oral
scientific communication, and 4) integrate clinical development with research training. In addition, the
collaborative research environment provided by the Center for Diabetes and Metabolic Diseases at the Indiana
University School of Medicine (IUSM), and the integrated clinical and research training received in the IUSM
Medical Scientist Training Program, will provide an excellent training environment. Also, an advisory committee
consisting of a diverse team of carefully selected and well-established investigators, along with a supportive
research environment in the laboratory, will further support and aid achievement of the proposed goals.

Public health relevance
PROJECT NARRATIVE β-cell stress pathways likely play an important role in activating or exacerbating the autoimmune response in Type 1 Diabetes. The pathway of autophagy has been implicated in disease development, but whether and how autophagy influences onset and progression of Type 1 Diabetes remains unclear. This project seeks to elucidate the utility of this pathway as a target for future therapeutics by seeking to understand the role of β-cell autophagy in cell survival, antigenic peptide production, and the β-cell-immune cell interface.